New Methods for Synthesizing Bioactive Peptides

Project Summary
Advances in organic synthesis have enabled the construction of increasingly complex peptide drugs and
natural products. However, access to many important peptides is still hindered or prevented by limitations in
current methods. Accordingly, the objective of this project is to discover new synthetic methods and apply them
to constructing bioactive peptide natural products. The hypothesis is that the proposed methods will enable
efficient construction of peptides that will be used to accelerate advances in medicinal chemistry and chemical
biology. The rationale for this idea is that pushing back the frontiers of peptide synthesis will unlock access to
unexplored areas of peptide chemical space, providing valuable new tools to medicinal chemists and chemical
biologists in the fight against disease. The hypothesis will be tested by pursuing three Specific Aims. Aim 1
involves devising a universal method of synthesizing ,-dehydroamino acids and streamlining their
incorporation into peptides. Eliminations of -nitroamino acids will be explored for this purpose. The process will
first be optimized in solution with model tripeptide substrates. Then, on-resin eliminations will be developed in
the context of a library of tunicyclin B analogs. Aim 2 entails determining the structure of the anticancer peptide
prethioviridamide through synthesis of the candidate diastereomers. A convergent approach involving late-stage
coupling of macrocycles and thioamide-rich hexapeptides will be pursued. The macrocycles will be synthesized
in solution, and the hexapeptides will be assembled on solid support. Aim 3 consists of developing a new serine
ligation protocol. The combination of carboxylate alkylation and O-to-N acyl transfer will be used to ligate peptide
segments and achieve macrocyclizations, with both processes occurring without epimerization. Various
electrophiles and N-methylated nucleophiles will be studied. Cyclic peptides ranging from four to eight residues
will be targeted by the macrocyclization investigation. The approach is innovative because it features the
development of novel synthetic methods such as eliminations of resin-bound -nitroamino acids, convergent
couplings of macrocyclic -thioenamides with linear polythioamides, and ligations that use the carboxylate as a
nucleophile instead of an electrophile. The significance of the proposed research lies in its ability to facilitate the
synthesis of peptides that can be used to solve important medicinal chemistry and chemical biology problems.
Such studies could include the use of ,-dehydroamino acids to impart rigidity and proteolytic stability to
bioactive peptides, the design and synthesis of potent and stable analogs of prethioviridamide as anticancer
agents, and the synthesis of medicinally relevant peptides via epimerization-free serine ligations. This project is
envisioned to create new synthetic methods that will facilitate exciting advances in medicinal chemistry and
chemical biology.

Public health relevance
Project Narrative This project involves the the discovery of new synthetic methods and their application to constructing peptide natural products. Most of the targeted peptides are biologically active, and some have potent anticancer activity. With the potential of spawning new therapeutic peptides for cancer and other diseases, this project is highly relevant to public health and to the mission of the NIH.